AIP inhibition of IRF7 and innate antiviral signaling

ABSTRACT
Interferon regulatory factor 7 (IRF7) is a transcription factor known as the master regulator of the type I
interferon (IFN) response; however, it remains unclear how IRF7 is negatively regulated to restore immune
homeostasis after viral infections are resolved. We have identified aryl hydrocarbon receptor interacting protein
(AIP) as a negative regulator of IRF7 that plays essential roles in the inhibition of IRF7 activation. AIP regulates
the aryl hydrocarbon receptor (AhR), a ligand-activated receptor of the host xenobiotic response to
environmental toxins such as 2,3,7,8-tetrachlorodibenzo-p-dioxin (TCCD). We found that AIP interacts with
IRF7 and this interaction is further enhanced by virus infection. Aip–/– murine embryonic fibroblasts (MEFs)
produce significantly more type I IFN compared to wild-type cells infected with virus, thus rendering these cells
highly resistant to virus infection. AIP antagonizes the nuclear localization of IRF7 to prevent the transcriptional
activation of type I IFN genes. However, key questions remain regarding the roles of AIP and AhR in the
regulation of IRF7 and innate immune responses. What is the molecular mechanism underlying specificity for
AIP regulation of IRF7 and antiviral innate immunity? Given the established functional links between AIP and
AhR, does AhR inhibit IRF7, and is AIP required for the inhibition of antiviral signaling by AhR ligands? In
preliminary studies, we have identified AIP as a novel substrate of the noncanonical IkB kinase TBK1 (TANK-
binding kinase 1), and three putative phosphorylation sites were mapped by mass spectrometry. Furthermore,
treatment of cells with the AhR agonist L-kynurenine (L-Kyn) significantly enhanced the replication of vesicular
stomatitis virus, providing evidence that AhR signaling inhibits the innate antiviral response. AhR interacts with
IRF7 suggesting that IRF7 may be a target of AhR in innate immune signaling. Indoleamine 2,3-dioxygenase
(IDO) is the rate-limiting enzyme in the generation of immune regulatory tryptophan metabolites, including the
AhR ligand L-Kyn. IDO is induced by IFN during virus infection suggesting that IDO participates in the negative
regulation of innate immune signaling. The central hypothesis driving these investigations is that AIP and AhR
cooperate as a functional unit to inhibit IRF7 and virus-induced type I IFN by a two-step negative feedback
mechanism instigated by TBK1 and the IFN axis. We will test our hypothesis experimentally with the following
Specific Aims: 1) Define the role of AIP phosphorylation in the inhibition of IRF7 and innate signaling, and 2)
Determine the role of AIP in the regulation of AhR during virus infection. Completion of these studies may
provide new mechanistic insight into how environmental factors can influence innate immunity to virus infection
and may provide rationale for the use of AhR agonists or antagonists as an approach to fine-tune host innate
immune responses in pathogenic settings such as autoimmunity or virus-triggered cytokine storms (e.g.
influenza A or SARS-CoV2/COVID-19).

Public health relevance
NARRATIVE The aryl hydrocarbon receptor (AhR) and its chaperone aryl hydrocarbon receptor interacting protein (AIP) regulate the host xenobiotic response to environmental toxins. The proposed studies will investigate novel functions of AIP and AhR as negative regulators of IRF7, a key transcription factor regulating type I interferon (IFN) and innate immune responses to viral infection. The proposed studies will reveal the mechanistic roles of AIP and AhR in the regulation of antiviral signaling, and may provide new insight into how environmental factors can impinge on the host immune response to virus infection and viral pathogenesis.